Enhancing Clinical Terminology to Enable Precision Mental Healthcare

PROJECT SUMMARY/ABSTRACT
The primary, long-term goal of this project is to improve outcomes for people living with mental health
conditions by enhancing technologies for semantic representation of mental, behavioral, and social
phenomena thereby enabling researchers, clinicians, and consumers to leverage the growing landscape of
computational methods and clinical decision support technologies to accelerate the rate of knowledge
acquisition and translation. This research will address gaps in both the content and ontological representation
of mental, behavioral, and social constructs. Ontologic representations are formal, explicit, computer-readable
definitions of the meaning of entities and occurrences in some domain. This research seeks to develop, build,
and evaluate high quality, machine-readable semantic models for mental, behavioral, and social processes,
findings (signs, symptoms, exposures, disorders), assessment instruments, and interventions. Focusing on two
highly important and diverse diagnostic constructs as test cases, borderline personality disorder (BPD) and
psychosis, the proposed work will cover a broad and representative sample of clinical constructs, processes,
findings, assessment instruments, and interventions that can be applied to many mental health conditions.
Data sources include electronic health records, publication metadata, narrative text in published, peer
reviewed research, existing terminologies and ontologies, and mental health subject matter experts, including
patients and families. Qualitative methods, including focus groups, the Nominal Group Technique (NGT), and
Delphi Method will be used to reach consensus about relevant concepts (clinical ideas), terms (clinical labels),
definitions, and relationships. Methods and Materials include ontology development methods and software
which will be used to physically build machine-readable ontologic models and terms. Models, terms, and
definitions created will be evaluated by domain experts, and shared with publishers of widely adopted national
and international clinical terminologies.
The career development plan will focus on acquiring knowledge and skills in formal terminology development
methods, qualitative methods, ontology definition languages, as well as conceptual models of both normative
and pathological mental functioning and psychological assessment methods. By creating ontologic models
capable of fully expressing the meaning of, and relationships among, mental, behavioral, and social constructs,
this project will create a foundation upon which additional clinical findings, disorders, assessments, and
interventions for mental, behavioral, and social constructs can be built. The substantial number of terms,
concepts, definitions, and relationships created through this study will be published and made available to
researchers, clinicians, and health systems for use in knowledge discovery and translation paradigms. This
work directly addresses the strategic goal of the National Institute of Mental Health (NIMH) to develop new
methods and tools to accelerate discovery and translation of new knowledge in behavioral science.

Public health relevance
PROJECT NARRATIVE This research will contribute to the acquisition and clinical application of knowledge about the complex interrelationships between mental, behavioral, social, and biological phenomena by enhancing standard, interoperable clinical terminologies to include mental, behavioral, and social processes, findings, assessments, and interventions. Unique identifiers and machine-readable definitions of, and relationships between, clinical constructs, processes, findings, assessment instruments, and interventions will enable the use of powerful new computational paradigms for knowledge discovery and improvement in care delivery.